Research Training in Systems Skin Biology

PROJECT SUMMARY/ABSTRACT
This new T32 application entitled Research Training in Systems Skin Biology is a combined pre- and post-
doctoral training program (MPIs Kim and Millar Co-PDs). The rationale for this proposal is that Icahn School of
Medicine at Mount Sinai (ISMMS) has a track record of success in dermatology, skin immunology, and epithelial
biology such that it can leverage additional institutional strengths (e.g., neuroscience, translational medicine,
etc.) to build an interdisciplinary training program in Systems Skin Biology. The central hypothesis is that such
intersectional science is critically important for the training of future scientists within single organ systems like
the skin. Finally, there is a major gap in our ability to train physician-scientist in a formalized manner which this
T32 would provide a platform to do successfully. The overall objective of this program is to attract and train
talented MD/PhD and PhD students and postdocs over 2 year periods, for successful, independent careers in
Systems Skin Biology relevant to human disease. We have a diverse, well-funded faculty with broad interests in
Systems Skin Biology in immunology and a strong pool of pre- and post-doc trainees that includes significant
numbers of underrepresented in science (UiS) minorities. The program is designed to provide training by
individual mentors performing research in all aspects of Systems Skin Biology relevant to human disease. The
program is supported with strong oversight and administrative structure, significant didactic training in Systems
Skin Biology, scientific writing and career development, and contains newly added state of the art evaluation
approaches with defined goals and benchmarks for success so as to optimize the development of independent
academic researchers in the field. The long-term goal of this program is to produce 1 MD/PhD or PhD scientist
in investigative dermatology/skin biology research every 2 years who become independently funded via a K or
R mechanism.

Public health relevance
PROJECT NARRATIVE Properly studying a single organ like the skin now requires a multidisciplinary approach that considers not only epithelial cells but also immune cells and even the nervous system. Thus, future trainees will require training in interdisciplinary science using a systems approach to marry different fields like neuroscience and immunology into one (e.g., neuroimmunology). This Training Program in Systems Skin Biology aims to build on the existing institutional strengths of Icahn School of Medicine at Mount Sinai (ISMMS) to create an intersectional science training program for both predocs and postdocs in Systems Skin biology.